GENETICALLY ENGINEERED T CELLS FOR DIPG

PROJECT ABSTRACT
Genetically engineered T cells for DIPG
The overall objective of this study is to engineer an effective and safe chimeric antigen receptor (CAR) T-cell
therapy for diffuse intrinsic pontine glioma (DIPG), a subgroup of diffuse midline gliomas for which currently there
is no cure. CAR T-cell therapy is an innovative technology based on adoptive transfer of antigen-specific T cells
engineered to elicit a clinically effective and specific immune response against tumor cells. Early clinical studies
in adult patients demonstrated the safety of CAR T-cell therapy for brain tumors, yet found only limited benefits.
This lack of efficacy is most likely multifactorial and includes T-cell exhaustion, the immunosuppressive tumor
microenvironment, and the paucity of brain tumor-specific antigens. Thus, we propose to develop CAR T cells
targeting glucose-regulated protein 78 (GRP78), a novel DIPG-specific antigen. To further improve the effector
function of GRP78-CAR T cells, we also propose to target a novel negative T-cell regulator called RASA2. We
hypothesize that CAR T cells targeting GRP78 on the surface of tumor cells and lacking RASA2 can be
developed as a safe, effective treatment for DIPGs and that evaluation of this intervention in DIPG mouse
models that closely mimic human disease will identify T-cell extrinsic negative regulators of CAR T-cell
function. Here we propose 3 interrelated Specific Aims to test this hypothesis. The rationale of each Aim is
outlined below. In Aim 1, we will first target GRP78 and optimize the CAR design. To that end, we will generate
CARs containing different co-stimulatory domains (41BB.ζ, MyD88.ζ, or MyD88.CD40.ζ) and compare their
activity in vitro. Then we will evaluate the efficacy and safety of the active CAR(s) in vivo by using
immunodeficient and immunocompetent mouse models of DIPG. A genome-wide screen in primary T cells has
identified key regulators of T-cell activation after T-cell receptor stimulation. One of the identified genes, RASA2,
has not been studied in T cells. In Aim 2, we will elucidate the mechanism by which the deletion of RASA2
enhances the effector function of CAR T cells and then delete the gene from GRP78-CAR T cells to enhance
their function. Finally, in Aim 3, we will characterize the components of the DIPG microenvironment and examine
the interactions between endogenous DIPG immune cells and CAR T–cell treatment. State-of-the-art methods
will be used in all 3 Aims to study not only the function and in vivo fate of CAR T cells but also their antitumor
activity and how they interact with DIPG-infiltrating immune cells (i.e., macrophages, eosinophils, monocytes).
Our preliminary studies indicate that prototype GRP78-CAR T cells readily recognize and kill DIPG cells in vitro
and have antitumor activity against solid tumors in vivo, highlighting that the developed models are well suited
for the proposed Aims. To support the rapid translation of findings from this project to the clinical setting, we will
use multiple DIPG mouse models that closely recapitulate human disease. Upon completion of this study, we
will have defined the optimal GRP78-CAR design that safely eliminates DIPG tumors and persists long term in
the DIPG immune microenvironment.

Public health relevance
PROJECT NARRATIVE Diffuse intrinsic pontine gliomas (DIPGs) are highly lethal pediatric brain tumors and a leading cause of cancer- related deaths in children. Chimeric antigen receptor (CAR) T-cell immunotherapy has the potential to improve outcomes in adult and pediatric patients with brain tumors; however, CAR design must be optimized and carefully evaluated in DIPG mouse models that closely mimic human disease. In this study, we propose to enhance CAR T–cell efficacy for DIPGs by optimizing the CAR co-stimulatory domain, silencing the negative T-cell regulators, and defining the inhibitory mechanisms in the DIPG tumor immune microenvironment that are activated by CAR T–cell treatment.